Clinician Scientist in Leukemia

This project is intended to support the applicant as a clinician-scientist in leukemia at Washington University School of Medicine / Siteman Cancer Center supporting NCI-funded clinical research. The applicant will support the implementation of clinical research at the institution by 1) improving operational efficiency, 2) expanding program capabilities, and 3) ensuring protocol compliance to achieve the highest quality conduct of clinical trials that can improve the lives of patients with cancer
The applicant will also provide scientific leadership to NCI-funded research as co-chair of the Leukemia Committee of the Alliance for Clinical Trials in Oncology and the Older AML Clinical Basket for myeloMATCH, the NCI Precision Medicine Initiative in myeloid malignancies. The Leukemia Committee of the Alliance will continue to conduct practice-changing treatment trials and further our understanding of the biological basis of leukemia and its treatment.
In older adults with AML, myeloMATCH will test the combination of targeted therapies with hypomethylating agents and venetoclax to improve remission rates and validate the prognostic significance of flow cytometry based measurable residual disease. A companion geriatric assessment will be implemented across treatment studies to validate measures that predict treatment tolerance and benefit.

Public health relevance
PROJECT NARRATIVE In 2021, it is estimated that there will be approximately 61,000 new cases with 23,660 deaths occurring from leukemia. The goal of this project is to reduce the impact of leukemia by supporting clinician-scientists conducting clinical trials sponsored by the National Cancer Institute at Washington University School of Medicine / Siteman Cancer Center and nationally. These trials will test novel therapies and prioritize a precision medicine approach where molecular testing is used to select patients who may most benefit from treatments targeting specific genetic abnormalities present in their leukemia.